Aging induced DNA double-strand break analysis in yeast

PROJECT SUMMARY/ABSTRACT
Aging is a primary risk factor for most chronic diseases. As the population of individuals over the age of 65
increases in the U.S., it is critical that we understand the molecular mechanisms that drive aging, with the goal
of delaying the onset of these chronic diseases. One of the “hallmarks of aging”, genomic instability, can occur
in the form of DNA double-stranded breaks (DSBs), which are lethal to cells unless resolved. In S. cerevisiae,
the ribosomal DNA (rDNA) is especially unstable due to its repetitive nature, high levels of transcription, and a
major replication fork block site. We are using the rDNA as a tool for studying the initiating genome instability
events of aging in dividing cells. Instability at the rDNA significantly contributes to the replicative aging of yeast
cells. Our lab previously demonstrated age-induced depletion of several factors that maintain rDNA stability,
including Sir2 and cohesin. During early aging, chromatin association by these factors was reduced at the
rDNA locus, followed by later reduction at centromeres, a combination that resulted in chromosome instability.
To identify additional factors that contribute to aging-induced rDNA and chromosome instability, we performed
a proteomics screen on nuclei isolated from replicatively young and moderately aged yeast cells. This screen
revealed depletion of multiple proteins that control chromatin topology and remodeling, especially at the rDNA.
These included topoisomerases I and II, and the DNA helicase Rrm3. Taken together, we predict a model
where reduced capacity to resolve DNA torsional stress during early aging results in DSBs at the rDNA. We
hypothesize that the repetitive rDNA array and accumulating extrachromosomal rDNA circles then act as a
“sink” for diminished DNA stabilizers and repair enzymes later in aging, ultimately contributing to genome-wide
instability.
To test this model, I am using a genome-wide DSB mapping and sequencing protocol in young and
progressively aged cells, focusing on hotspot identification across multiple time-points (Aim1). In preliminary
experiments, I have optimized this method for yeast and confirmed the rDNA as a DSB hotspot, even in young
cells. I will also look for changes in distribution across lifespan of the key proteins identified in our proteomics
screen using ChIP-seq. Third, I will determine if aging sensitizes cells to DSB inducing agents. In Aim2 I will
determine if DSB accumulation in early aging can be rescued by re-expressing key age-depleted factors using
a titratable, doxycycline-inducible overexpression system. Second, I will determine if re-expression of the
candidate age-depleted proteins reduces rDNA stability or extends replicative lifespan. These experiments will
give insight into how genomic instability acts as a driver for the initiating events of aging.

Public health relevance
Project Narrative Aging is a major risk factor in many chronic diseases, including cancer and heart disease. Due to the rapidly increasing population of individuals over the age of 65 in the U.S., there is an urgent need to better understand the molecular drivers of aging in order to delay or prevent the onset of these age-related diseases. My proposal aims to use replicatively aged Saccharomyces cerevisiae (budding yeast) as a model organism for studying the initiating events of aging, specifically the role of DNA double-strand breaks and age-dependent depletion of chromatin factors in genomic instability.